Small Molecules and Biologics Toxicology Consultant Support Services

The NINDS Subject Matter Expert Consultant for Toxicology provides technical guidance provide technical guidance to the following programs:
• Toxicology consulting support to the NIH Blueprint Neurotherapeutics Network [BPN] drug discovery and development programs.
• Toxicology consulting support to the Help End Addiction Longterm [HEAL] drug discovery and development programs.
• Other NIH neuroscience-focused drug discovery and development programs

The NIH Blueprint for Neuroscience Research, a consortium of 8 NIH Institutes and Centers that support neuroscience research, established the Blueprint Neurotherapeutics Network (BPN) as a pipeline between the typical endpoint of NIH-funded research and the beginning of industry drug development. The BPN provides neuroscience researchers with funding and access to a full range of industry-style drug development services and expertise. The program is intended for projects requiring medicinal chemistry optimization and contract research organization (CRO) support through Phase I clinical testing. Each project is directed by a Lead Development Team (LDT) composed of the principal investigator (PI), industry consultants hired by NIH, and NIH staff. This team maps out a research strategy, including milestones, and oversees implementation by CROs.